CORE C: HUMAN SUBJECTS CORE

PROJECT SUMMARY/ABSTRACT
CORE C: HUMAN SUBJECTS CORE
The Human Subjects Core (HSC) is designed to support investigators in clinical measurement, recruitment,
and compliance through centralization of services and expertise. Research programs that involve human
subjects encounter challenges related to standardized testing, recruitment of special populations, and
regulatory compliance. Time, effort, and resources are required to overcome these barriers, and individual
investigators and their laboratories rarely have the capacity to address them without consequences to
productivity. The HSC addresses these challenges through two integrated programs (1) a Clinical
Measurement Program (CMP), and (2) a Recruitment and Quality Assurance Program (RQP). These programs
are designed to provide investigators access to clinical experts, recruitment support, data sharing, and staff
supports in compliance and quality monitoring. These centralized supports have led to increased efficiency,
collaboration, and productivity in the research program during Phase I. In Phase II, we plan to continue these
effective programs while also expanding our efforts by recruiting and testing children with developmental
language disorders, by updating and integrating our databases, and by implementing plans that will increase
the financial self-sufficiency of the HSC over time.